The University of Texas MD Anderson Cancer Center SPORE in Melanoma

Overall: Project Summary/Abstract
Melanoma is the deadliest form of skin cancer, with an increasing incidence and mortality, and a 5-year
survival rate less than 20% for patients with metastatic disease. Several recent landmark genomic and
immunologic studies have generated important new insights into the pathogenesis, drivers, and regulators of
this disease, translating into the approval of both targeted and immune therapies for patients with metastatic
disease. While targeted therapies have achieved high response rates, they are generally transient; likewise,
immunotherapies bring about dramatic, long-term, complete responses but only in a subset of patients and
often with serious toxicities. Despite the progress that has been made, several key challenges remain to
maximizing the clinical benefit of immunotherapy: 1) poorly understood markers and mechanisms of
resistance to immunotherapy, and a lack of effective strategies to overcome them; 2) limited experience or
efficacy in patients with central nervous system involvement, a common metastatic site and cause of death for
melanoma and other cancers; and 3) lack of any benefit from single-agent immunotherapies in patients with
non-cutaneous melanomas, particularly the uveal melanoma subtype. The central hypothesis of this SPORE
proposal is that an integrated analysis of immune and molecular features in patients with advanced
melanoma will improve our understanding of response and resistance to immunotherapy, and lead to
more effective treatments. To test this hypothesis, we will focus on the most critical unmet needs of
melanoma patients, building on current immunotherapeutic strategies and developing our own novel
concepts to identify more effective treatment options by pursuing the following specific aims:
• Address resistance to the PD-1 immune checkpoint inhibitor through inhibition of the PI3K pathway in PTEN-
null metastatic melanoma patients (Project 1).
• Determine the clinical utility of PD-1 blockade using nivolumab administered intrathecally in metastatic
melanoma patients with leptomeningeal disease (Project 2).
• Evaluate a new therapeutic strategy for uveal melanoma that uses adoptive cell therapy to target an
immunogenic epitope of melanosomal transport protein SLC45A2 (Project 3).
Three cores (Administrative Core, Clinical Database, Tissue Resource, and Translational Pathology Core
[Core 2] and Biostatistics and Bioinformatics Core [Core 3]) provide specialized services to support our SPORE
investigators and their proposed research studies. Together, these three projects and cores and our
Developmental Research and Career Enhancement Programs will provide a comprehensive attack on critical
unmet needs for patients battling these deadly manifestations of melanoma, and pave the way for other
cancers with limited therapeutic options.

Public health relevance
Overall: Narrative An unprecedented number of novel and highly potent agents including the revolutionary checkpoint inhibitors have changed the landscape of melanoma therapy in recent years; however, only small subsets of patients show meaningful clinical benefit, many experience significant toxicity, and resistance to these therapies is an ongoing challenge. Our SPORE in Melanoma seeks to develop new, rational, and more effective combinatorial therapy approaches to identify effective treatment strategies for patients with critical unmet needs, including those battling advanced, refractory cutaneous and uveal melanoma, and leptomeningeal disease. To that end, we will explore novel approaches including various forms of adoptive cell therapies and microbiome modulation, to enhance our understanding of the immune response and, ultimately, extend the potential clinical benefits of these novel therapies to all patients with melanoma.